Biospecimen and Pathology

PROJECT SUMMARY (Biospecimen and Pathology Core)
The translational research proposed in the MD Anderson Cancer Center Prostate Cancer SPORE requires a
broad range of comprehensive support. The Biospecimen and Pathology Core supports investigators by
providing (1) a biospecimen resource with clinically and pathologically annotated biospecimens that
encompass the clinical spectrum of prostate cancer; (2) clinically relevant patient-derived xenografts reflective
of the clinical challenges addressed in the projects; (3) clinical and laboratory personnel experienced in the
conduct, collection, and processing of specimens from clinical trials; and (4) dedicated pathologists and
clinicians with technical expertise who will conduct and interpret tissue-based studies and coordinate all core
activities. To maximize analyses using small samples and enhance collaboration among investigators at MD
Anderson and other institutions, Core personnel will prepare and distribute tissue derivatives linked with
specific disease states. Close collaboration with investigators and electronic processing of requests for
biospecimens and clinical information by the Tissue Acquisition and Distribution Committee will ensure the
evolving needs of each project will be met in a timely manner. In addition, the Core’s Prometheus informatics
staff will manage the repository for clinical and translational data so that investigators will have the full power of
detailed, well-curated clinical annotations essential to maximizing the information gained from often small
samples. The Prometheus system also facilitates the interpretation of analyses within specific clinical and
biologic contexts and enhances interactions among projects. Other functions of Prometheus are to ensure
common data format and ontologic term usage, data integrity, audit history, and data security. Prometheus will
also facilitate future data exchanges with investigators and SPOREs at other institutions. Finally, Prometheus
will enable all statistical analyses performed in the Biostatistics and Bioinformatics Core to be carried out using
the most up-to-date clinical and translational data.

Public health relevance
PROJECT NARRATIVE (Biospecimen and Pathology Core) The Biospecimen and Pathology Core personnel will collect, store, perform quality control measures, annotate, and distribute tissue and blood specimens obtained from patients with prostate cancer. They will also create and maintain cell lines and xenografts from specimens of prostate tumors. The core personnel will also provide technical support and pathological expertise to the investigators and link the clinical and pathological information with the results obtained in the various experiments.